The Epidemiology and Somatic Genomic Pathogenesis of Radon-Related Stroke

Project Summary/Abstract
Although stroke is a major contributor to disability and mortality worldwide, established stroke risk factors have
not fully explained the observed burden of or spatial variation in its incidence. Indeed, nearly a third of strokes
are cryptogenic, thereby compelling a search for environmental factors that may play an important, but to date,
inadequately characterized role in stroke pathogenesis and epidemiology. One such factor—radon—is a
naturally occurring, odorless gas generated via decay of radioactive elements in rocks and soils. The gas enters
homes through basement and foundation cracks, making unrecognized exposures both ubiquitous and the
second-leading, modifiable cause of lung cancer in the US, after smoking. Although radon’s role in lung
carcinogenesis is well-known, relatively little is known about its role in the pathogenesis and epidemiology of
cerebrovascular disease. Yet extant studies of the radon-stroke association suggest that radon exposure is
associated both with pathologic precursors of stroke and incident stroke, itself. Their collective limitations
nonetheless leave a substantial gap in the state of the science that could otherwise highlight putative means of
reducing radon exposures and their common cerebrovascular sequelae in the US. To fill this gap, we will
therefore estimate: [1] pre- and post-mitigation home radon exposures across the US (1986-2018), [2] the
association between time-varying home radon exposure and incident stroke, [3] the association between time-
varying home radon exposure and clonal hematopoiesis of indeterminate potential (CHIP), and [4] mediation of
the radon-stroke association by CHIP. We will do so among a demographically and environmentally diverse
group of 194,015 participants in three NHLBI-supported cohorts that have reviewed and approved this proposal.
Quantitatively estimating radon exposures and their uncertainties at their accurately geocoded addresses will
involve a national, spatiotemporal prediction and two-stage cross-validation based on time-varying, short- and
long-term mean, pre- and post-mitigation home radon concentrations; home radon testing statistics / policies;
and housing characteristics; plus, time-invariant aerial gamma-radioactivity, geology, and soil features.
Estimating radon-stroke and radon-CHIP associations also will involve cohort-specific, multivariable-adjusted,
Bayesian, hierarchical, time-to-event and logistic regression accounting for exposure uncertainty and competing
mortality, followed by inverse variance-weighted, random-effects meta-analysis. Finally, estimating mediation of
the radon-stroke association by CHIP will involve quantifying direct, indirect, and total effects of radon on stroke.
The previously unparalleled focus of such estimation on a modifiable risk factor, a plausible mechanism of
disease, and a common, clinically and societally burdensome health outcome heretofore ignored by EPA and
WHO uniform radon testing and mitigation policies will thereby position the study to help characterize the
environmental epidemiology and somatic genomic pathogenesis of stroke and other health outcomes in ways
that may lead to the identification of plausible targets for new public health screening and prevention efforts.

Public health relevance
Project Narrative By rigorously investigating radon as a novel risk factor for stroke, the proposed study will augment understanding of a putative somatic genomic mechanism by which a naturally occurring carcinogen may increase susceptibility to a societally burdensome form of cerebrovascular disease and highlight the potential value of targeted testing, radon-safe construction, and mitigation in stroke prevention, with the ultimate goal of informing health policy and improving cerebrovascular health in the US.